The role of IL-37 in human regulatory T cells, Supplement

PROJECT SUMMARY/ABSTRACT
This proposal is a supplement to R01 AI156534, “The role of IL-37 in human regulatory T cells,” designed to
enhance the training of Dr. Cameron Lloyd, PhD, who will be hired as a postdoctoral fellow in the Department
of Dermatology at the University of Colorado, Anschutz Medical Campus. Understanding peripheral tolerance
and the maintenance of immune system homeostasis is vital in the control of human diseases. We have
previously demonstrated that the anti-inflammatory cytokine IL-37 participates in immune tolerance by
generating semi-mature tolerogenic dendritic cells (DCs) in antigen-specific adaptive immune responses. IL-37
is one of eleven IL-1 family members and the only known member to be broadly anti-inflammatory. In our
recent project, we found IL-37 levels were elevated in multiple human immune cell types, specifically in
regulatory T (Treg) cells. Our further analysis revealed that human Treg cells express the highest IL-37 levels
among all T-cell subsets and that intracellular expression of IL-37 correlates with the expression of master
transcriptional regulator, FOXP3, in human Treg cells. Therefore, in the parent grant proposal (R01 AI156534),
we hypothesized that the expression of IL-37 upregulates and stabilizes FOXP3, thereby maintaining Treg
stability and highly suppressive function in human Treg cells, and we proposed 3 Aims to define transcriptional
and translational regulations of IL-37 expression in human Treg cells, molecular mechanisms of IL-37
expression in mediating FOXP3 expression and immune suppression, and the role of IL-37 in human Treg cell
heterogeneity. Here, supplemental funding is requested for Dr. Lloyd’s post-doc fellowship to propose an
extension to the parent project. The project utilizes human primary Treg cells and various disciplines from
immunology, cell biology, molecular biology, and protein chemistry, which would enhance the training of Dr.
Lloyd, who has been trained in molecular biology and microbiology. The University of Colorado has a strong
Immunology & Microbiology training record, and Dr. Lloyd will have a strong mentor team. Since our proposal
uses human T cells, the results could be easily translated into clinical medicine and patient care. The findings
will have an immense translational impact on many human diseases, such as autoimmunity and
transplantation.

Public health relevance
PROJECT NARRATIVE Immune tolerance is vital in preventing immune dysregulation and autoimmunity. This proposal is a supplement to R01 AI156534, “The role of IL-37 in human regulatory T cells,” designed to enhance the training of Dr. Cameron Lloyd, PhD, who will be hired as a postdoctoral fellow in the Department of Dermatology at the University of Colorado, Anschutz Medical Campus.